Investigating the development and regulation of the extrafollicular B cell response as a programmed response type

Abstract This is a proposal to advance our basic understanding of a critical but understudied aspect of
immunity—the extrafollicular (EF) response. Upon activation, B cells enter either the EF response, or the
germinal center (GC) response. The GC gives rise to high affinity memory B cells and long-lived plasma cells
(PC), crucial elements of vaccine responses. While the GC is highly studied, the role of the EF response and
how it is generated is much less well understood. Yet, the biology of the EF response is likely to be highly
relevant to human health: Recent studies highlight the importance of the EF response, both in controlling
infection and in dysregulated contexts such as Lupus and severe COVID infection. We have recently identified
IL-12 as an upstream cytokine switch that directs B cells toward the EF response and suppresses GCs. In B
cells, IL-12 induces autocrine feed-forward signaling between IL-12 and IFNg, resulting in distinct
transcriptional changes and enhanced PC differentiation. B cells secrete IL-12, which promotes both their own
differentiation and surprisingly, early TH1 differentiation. IL-12/IFNg signaling also induced the expression of
CXCR3 by B cells, known to facilitate DC:T cell interactions during TH1 responses. DCs have also been shown
to enhance PC differentiation in some contexts. EF foci form in locations rich in DCs and T cells, but the
significance of this location is unknown. These findings lead to our central hypothesis - that the EF response is
a specialized “response type” preferentially supporting rapid expansion and PC differentiation, and that EF foci
are a niche with local cell-cell interactions and cytokine production, coordinated by inflammation-induced
chemokines. GC B cells facilitate the differentiation of TFH, and though naïve B cells can invade existing GC,
the bulk of the GC population is maintained through proliferation with infrequent differentiation. In Aim 1, we will
test the role of B cells in enhancing the EF response locally, and test the self-renewal capacity of the
undifferentiated “EF B cell” population. In Aim 2, we will isolate the continually proliferating EF B cell population
and begin to characterize the EF B cell state transcriptionally and epigenetically. We will examine the effects of
IL-12 and IFNg on this gene regulatory network. We will also target transcription factors that are predicted to
regulate the EF B cell program and test these findings using human B cells. In Aim 3, we will characterize the
EF foci as a niche, much like the GC is thought of, using spatial transcriptomics and genetic approaches to
define the roles of DCs, CD4 T cells, and CXCR3 in the EF response. Collectively these studies will provide a
significant conceptual advance for our understanding of the EF B cell response and enable the creation of new
tools to study EF B cells and their progeny. This is an area of great need as relatively little is known about how
the EF response is regulated. These studies are therefore poised to have a significant impact in advancing our
understanding of the EF response, with a long-term objective of learning how to both restrain EF responses to
treat EF-driven autoimmunity, and exploit the EF response for novel vaccine designs and cancer therapeutics.

Public health relevance
Project Narrative: Upon activation, B cells enter either the Germinal Center or the Extrafollicular response, the latter being the dominant pathway observed during many infections and autoimmune diseases, yet it is highly understudied. We have found that IL-12 is a molecular switch that promotes this response, which has led us to the identification of B cells that sustain it. Here we will investigate the regulation and effects of these cells to elucidate novel pathways to treat a wide range of disease settings where this fundamental B cell response type is dysregulated.